CLINICAL VALIDATION OF NATUS ETCO BREATH ANALYZER

The purpose of this study is to validate measurements of end tidal carbon monoxide (ETCO) and ETCO2 as well as respiratory rate obtained with the Natus Breath Analyzer by comparing them with values obtained by standard measurement devices (Pyron CO2 monitor, Viatograph Breath CO). Increased CO excretion occurs in conditions in which heme metabolism is increased, such as hyperbilirubinemia. Current techniques require the cooperation of the test subjects, making them inappropriate for use in infants, young children and unconscious persons. The two methods will be compared statistically to determine the validity of the Natus device measurements.